Administrative Core

SUMMARY
The objective of the Administration Core A is to support the performance of the research outlined in this
application for the Viral Immunity and Vaccination (VIV) Human Immunology Project Consortium (HIPC). The
Administration Core A is directed by the application’s multiple Principal Investigators (MPI), Ana Fernandez-
Sesma, PhD and Viviana Simon, MD, PhD with the help of a full time Project Coordinator. Core A will have an
organizational structure with defined roles for administrative and scientific staff. It will oversee the activities
involving research, collaboration and communication. Ongoing assessments will ensure the allocation of
resources, core usage and other policies. Core A will create an integrated research environment to overcome
the scientific and management problems that are a natural part of a multi-center collaboration. An Internal
Scientific Advisory Group (ISAG) composed of the Project and Core leaders will act in an advisory capacity,
providing perspectives on the program research. A strategic plan developed by the ISAG will provide a
framework to identify and prioritize needs and guide the future of the research program. The plan will place
special emphasis on addressing the organizational, operational, and scientific issues identified by the
participating collaborators, as well as in synergizing with other investigators within the HIPC network. Its
purpose will be to maintain academic and research excellence, and readiness to exploit new scientific
opportunities. Core A will also convene an External Scientific Advisory Group (ESAG) that will act in an
advisory capacity, providing external perspectives on the program research and helping to expand and
intensify external collaborations. The proposed activities and services of the Administrative Core A are: Aim
1) To perform program coordination, communication, and management, Aim 2) To prioritize, allocate, and
manage resources and Aim 3) To have a management plan for fiscal accountability and communication within
the program.